PHASE II TREATMENT WITH ORAL ALL-TRANS RETINOIC ACID,INTERFERON, AND DOXORUBICIN

This study proposes to test the response rate of cervical cancer to combination therapy with all-trans retinoic acid, interferon, and doxorubicin; to determine whether any correlation exists between tumor response and presence of interferon receptors on pre-treatment biopsy; to determine effect of chronic dosing and interferon treatment on plasma levels of all-trans retinoic acid.